OPtimizing Technology to Improve Medication Adherence and BP Control (OPTIMA-BP).

PROJECT SUMMARY
Hypertension disparities persist and are particularly worst in African Americans (AA). Suboptimal hypertension
self-management, including adherence to medication-taking of antihypertensives remains a major public health
concern. Poor adherence to antihypertensive medications is estimated to occur in 43-78% of patients, with
approximately 50% discontinuation after a year, and worse in AA. Even more alarming, AA older adults may not
be prescribe evidence-based practice treatment regimens known to more efficient in the AA population. There
is a critical need for behavioral approaches and long-term self-management strategies that are feasible,
replicable, and scalable. Mobile Health (mHealth) technologies (mobile phone applications [app], text, video
messaging) are promising tools to facilitate behavioral change and sustain self-management.
While reports support using mHealth technologies for the management of chronic diseases have grown,
there is limited data specific to AA older adults. Other gaps identified in the literature regarding mHealth
technology include the lack of being theoretically driven, the clinical/epidemiologic investigations are primarily
conducted outside of the U.S. limiting generalizability, and the lack of evidence on long-term sustainability and
impact on clinically relevant health outcomes. This R01 application, OPtimizing Technology to Improve
Medication Adherence and BP Control (OPTIMA-BP) is testing a technology-based interventions compared to
a wait-listed control (WL) in a prospective, randomized controlled trial (RCT) design. OPTIMA-BP includes
evidenced-based strategies, web-based education, and behavioral skills training to use a theoretically driven
mHealth medication management app in conjunction with a guideline directed treatment regimen and nurse
counseling.
The aims of this study are: [1] To test the effects of OPTIMA-BP vs. WL on systolic BP and serum high-
density lipoprotein cholesterol (HDL) in AA older adults with hypertension in a prospective, RCT format; and [2]
To test if the attitudinal/knowledge mechanisms of self-management (hypertension knowledge, self-efficacy,
perceived social support) and proximal behavioral target mechanisms (taking medications to reduce systolic BP,
diet, exercise) mediate OPTIMA-BP vs. WL’s impact on the primary and secondary outcomes (systolic BP,
diastolic BP, health-related quality of life, serum lipids, and at least 62% of the sample with BP <130/80 mmHg)
over a 12-month time period. A secondary aim of this study will assess OPTIMA-BP and WL’s impact on the
primary and secondary outcomes while controlling for covariates/contextual variables such as age and gender.
A supplemental and complementary feature of this proposal is the qualitative evaluation to confirm self-
management barriers and perceived strengths or limitations of the intervention, which will inform future
refinements should these RCT findings be positive.

Public health relevance
PROJECT NARRATIVE The prevalence of hypertension and cardiovascular related consequences remain high in African Americans (AA), despite treatment advances and evidence-based practice guidelines that have shown positive results in blood pressure control. Mobile Health (mHealth) technologies are promising tools to facilitate behavioral change and sustain self-managing chronic diseases; however, there is a lack of evidence of mHealth long-term impact on clinically relevant health outcomes and data specific to AA older adults. The proposed project will test a technology-based intervention approach, OPtimizing Technology to Improve Medication Adherence and BP Control (OPTIMA-BP), focused specifically on AA older adults with hypertension to improve hypertension self- management, medication adherence, and blood pressure control.